Biostatistics & Data Science Core

(CORE C- BDSC: BIOSTATISTICS & DATA SCIENCE CORE)
PROJECT SUMMARY
Description: The Biostatistics & Data Science Core (BDSC) provides comprehensive and expert analytic tools
for IDDRC users desiring support in quantitative experimental design, biostatistics, and informatics techniques
with particular emphasis on machine learning. The Core has substantive expertise in areas represented by two
sub-cores (1) Biostatistics, with faculty from the Department of Biostatistics, Epidemiology & Informatics at the
University of Pennsylvania (PENN) supporting experimental design of basic science, clinical trials and
observational studies and the analysis of the ensuing data (2) Informatics and machine learning, with faculty
from the Department of Biomedical Health Informatics at Children’s Hospital of Philadelphia (CHOP), providing
support for high-level data integration of ‘omics’ data along with interpretation, classification and predictive
modelling. A third sub-core will support Career Development and Education. Core members are committed
mentors and teachers. Dr. Mary Putt, Professor of Biostatistics and former Associate Vice-Chair of the Graduate
Group in Epidemiology & Biostatistics and Program Chair of the Biostatistics graduate program, is the overall
Core Director and Director of the Biostatistics Sub-Core. Dr. Kai Wang, Associate Professor of Biomedical
Health Informatics at CHOP and Pathology (PENN) and, and Senior Fellow of the Institute for Biomedical
Informatics, is Associate Director of the Informatics & Machine Learning Sub-Core. Dr. Rui Xiao, Associate
Professor of Biostatistics, and Pediatrics, is Associate Director of the Career Development & Education Sub-
Core
Relevance to IDDRC Mission: The BDSC supports the overall themes of our IDDRC, specifically (1) impactful
research into the cause and treatment of conditions related to intellectual and developmental disability (IDD) and
(2) career development and education of a new generation of IDD researchers. The BDSC evolved out of the
previous Biostatistics & Bioinformatics core; it interacts with and/or complements the activities of the other IDDRC
Cores as well as the Research Project. The Biostatistics faculty (Drs. Putt and Xiao) from this well-established
core have joined forces with colleague, Dr. Kai Wang, expert in Informatics and Machine Learning to form the
new Biostatistics & Data Science core. The Biostatistics faculty, through long association with the IDDRC, are
integrated into multiple domains of IDD biomedical research, from basic science to clinical and translational
medicine. Dr. Wang, through his expertise in machine learning and other informatics approaches, his recently
established collaborations with IDDRC members and extensive experience in brain disorders, adds a new and
exciting angle to the new generation of big data analytics and training.
Eligibility: These services are available both to approved users of the IDDRC at Children’s Hospital of
Philadelphia/University of Pennsylvania (CHOP/PENN) and to users at Centers throughout the IDDRC Network.